Somatic mutation rates in healthy aging

PROJECT SUMMARY/ABSTRACT
Somatic mutations accumulate over time in every healthy cell, and these mutations have long been
hypothesized to be an important contributor to aging. However, many unknowns remain about this fundamental
process of aging because only recently have ultra-high fidelity sequencing technologies become available that
can detect somatic mutations in bulk poly-clonal samples of healthy cells, such as blood. For example, it is
entirely unknown how widely aging-related somatic mutation rates (SMRs) vary among individuals in
the population, whether SMRs predict mortality and aging-related disease, whether genetic or
environmental modifiers may cause outlier SMRs, and whether SMRs are associated with epigenetic
aging of the genome. Notably, no study to date has measured SMRs in large numbers of individuals, and no
study has measured SMRs with associated individual health, lifestyle, and exposure data. The Women’s
Health Initiative and the Cancer Prevention Study-II Nutrition Cohort are longitudinal studies that present a
unique opportunity to study the variability, modifiers, and mechanisms of SMRs in the human population.
These cohorts’ > 20 years of longitudinal data and blood samples from > 20 years ago enable this
proposal’s first large-scale measurements of SMRs in the human population and the first
measurements of SMRs in combination with detailed human health data. Here, we will perform ultra-high
fidelity profiling of SMRs and mutational patterns in the blood of 3,000 individuals from these cohorts, which is
almost an order of magnitude more individuals than all prior SMR studies combined. This study will directly test
several fundamental open questions and hypotheses about SMRs, including how widely SMRs and mutational
patterns vary among individuals, whether SMRs vary between sexes, whether there are outlier individuals in
the population with identifiable causes for their higher or lower SMR, and whether SMR predicts mortality and
aging-related disease. Since prior studies suggest that deamination of methylated cytosines is a significant
contributor to SMRs, we will also perform the first joint SMR and methylation profiling of the same individuals to
assess the mechanistic relationship between genetic and epigenetic aging of the genome. Apart from
achieving the first population-level characterization of SMRs and an improved mechanistic understanding of
SMRs, this study may establish SMRs as a novel, clinically useful biomarker for healthy aging. As the
population ages and the prevalence of aging-related diseases increases, our study may motivate the use of
SMRs as a biomarker for predicting aging-related disease risk, potentially enabling early preventive clinical
interventions. This study will further establish a scalable approach for studying SMRs—which reflect the
cumulative effect of endogenous and exogenous mutagens over the lifespan—in large cohorts, with potential
for significant impact on our understanding of human health and aging.

Public health relevance
PROJECT NARRATIVE Genetic mutations accumulate in every cell of our bodies throughout our lives, and these mutations have long been thought to be an important reason why our bodies age. However, it is not known whether some people accumulate mutations at a faster or slower rate with age, and whether differences in the rate at which mutations occur might predict how long we live and the risk for aging-related diseases. This study will answer these questions by measuring the mutation rate of a large number of people, which may allow us to predict, and understand why, people age differently.